Mechanobiology of Cardiac Outflow Tract Morphogenesis

PROJECT SUMMARY
Proper growth, septation, and maturation of the cardiac outflow tract (OFT) into valved aortic and pulmonary
outlets are essential for oxygenated circulation after birth. 1-2% of live births and up to 30% of pre-term fetal
deaths have congenital heart defects, many of which affect the remodeling of the valvuloseptal primordial tissues,
called the proximal and distal outflow cushions. Despite much effort uncovering the genetic basis of early OFT
cushion formation, this understanding has not explained the clinically relevant phases of growth, condensation
and elongation into valves and septa. Further, emerging evidence suggests that the formation, growth, and
maturation of the valvuloseptal appratus is coupled with that of the ventricles. Gross congenital valve
malformations induce hemodynamic changes within the developing ventricles (via stenosis and/or regurgitation),
leading to structural differences in their myofiber architecture and trabecular patterning. While many of these
malformations are gestationally survivable, structrural valvular defects like mitral valve prolapse, which have a
developmental origin, also incur premature ventricular failure and risk of sudden death. It is currently unknown
how hemodynamic perturbations drive shared fetal ventricular and valvular remodeling, in part because
prevailing genetic tools lack the power to separate genetic from hemodynamic causality. The Butcher lab has
pioneered innovative technology 1) to quantify local in vivo mechanical forces within cardiac inflow, ventricular,
and OFT domains, and register them with local in situ gene/protein expression, 2) to non-invasively visualize
and precisely ablate intracardiac tissues without collateral damage in vivo, and 3) to directly assess local spatial
cellular transcriptomes across entire thin sections. This CAROL Act Supplement will expand the current funded
project to interrogate how valvular and ventricular remodeling is coupled to their shared hemodynamic
environment. First, emerging state of the art high-resolution spatial transcriptomics will be applied to achieve first
ever true single-cell spatial resolution across full-size fetal heart domains (10x10 mm areas). This will be applied
to uniquely identify inflow atrioventricular, ventricular, and outflow tract cellular transcriptional profiles in embryos
treated with sham or hemodynamically perturbed conditions leading to established cardiac structural
malformations. This will be further performed at early and late stages of malformation, enabled by an innovative
device for precise planar application of cryosections. Next, we will apply novel cellular neighborhood analysis
tools to determine unique and shared neighborhoods that associate with local structural changes in the
atrioventricular valves, compact and trabecular ventricular domains, and outflow tracts. Cellular neighborhood
candidates will then be verified by secondary immunofluorescence methods. These results will dramatically
improve our understanding of how valve-related malformations induce undesirable ventricular remodeling
towards impaired functional longevity, and identify multi-cellular fingerprint signatures that could be predictive of
these risks.

Public health relevance
PROJECT NARRATIVE Many congenital malformations affect both the ventricles and valves due to their shared perturbed hemodynamic environments. This CAROL Act supplement applies innovative experimental technology, high resolution spatial transcriptomics, and computational bioinformatics to identify novel coupled molecular and cellular changes within valves and ventricles that govern systemic cardiac malformation and early failure risk.